Administrative Core

The Administrative Core will bring together kidney, non-malignant urology and hematology training activities in
pediatric and adult medicine of five highly supportive Harvard sites (Brigham and Women’s Hospital (BWH), Beth
Israel Deaconess Medical Center (BIDMC), Boston Children’s Hospital (BCH), Massachusetts General Hospital
(MGH), and Harvard Medical School Division of Medical Sciences (HMS-DMS)). Led by Dr. Bonventre, the
Administrative Core is responsible for program organization, governance, collaboration, communication, as well
as evaluation and continuous improvement of the Harvard Kidney, Urology and Hematology Training Institute
(HKUHTI) and proposes the following Aims. Aim 1. Establish a diverse collaborative administrative and
governance structure for training across three disciplines (Kidney, Urology, and Hematology) at BWH,
BIDMC, BCH, MGH, HMS-DMS and affiliated research centers in pediatric and adult medicine to oversee
the recruitment and training progress of a diverse next generation of exceptional leaders in KUH-focused
research, coordinated within the national NIDDK KUH Network. The Core will provide coordination of the
activities of the Professional Development Core (PDC) and Network Core to optimize the training of a diverse
cohort of pre-and postdoctoral trainees funded by the TL1 training component. Governance will be inclusive with
each of the highly committed primary institutions being represented on an Executive Steering Committee (ESC)
that will meet monthly as well as all other committees of the HKUHTI. The Recruitment, Selection and Retention
and the Mentors and Trainee Evaluation Committees of the TL1 will have representation on the ESC. There will
be an Internal Advisory Board and External Advisory Board that will meet at least yearly. A Diversity, Equity and
Inclusion Committee will span the U2C and TL1. The Core will coordinate predoctoral and postdoctoral trainee
activities with high school and undergraduate programs that we have in place. We will plan to organize one of
the annual NIDDK face-to-face meetings. Aim 2. Establish research training milestones and implement
validated methods to track, monitor and evaluate HKUHTI success with focus on research training,
mentoring and career/network development. While one-on-one mentoring will remain a keystone of the re-
imagined training program, the program will also provide a strong emphasis on developing mentoring networks and
multidisciplinary team science. The ESC will set goals, objectives, and desired outcomes and targets for
achievement based on review of feedback, outcomes, and mentoring activities. Aim 3. Create a “Hub” web
portal to serve as the overall home of all things related to the HKUHTI and a platform for ongoing
collaboration, monitoring and evaluation. The Hub will serve as the source for all program-related information
and will be developed and maintained in collaboration with other Cores and TL1 leadership. The website will host
trainee, mentor and alumni profiles, event calendars, announcements, webcasts of seminars, didactic content,
trainee accounts, social media and interactive forums for trainees to exchange ideas and troubleshoot problems.